Active chromosome movement in meiotic pairing

PROJECT SUMMARY
Homologous chromosome pairing during meiosis is a central process underlying Mendelian inheritance, in
which homologous chromosomes move through the nuclear interior to locate and pair with their homologs,
prior to synapsis via the assembly of the synaptonemal complex (SC). Failure of this pairing process can
result in aneuploidy. Much of the effort to understand meiosis has focused on determining genes involved in
homology recognition and recombination, but the physical process by which chromosomes come together
inside the densely packed nucleus remains poorly understood. In order to pair successfully, chromosomes
must carry out a huge number of homology tests while avoiding interlocks that would prevent complete pairing.
Meiotic chromosome movement is facilitated by forces, generated by the cytoskeleton and motor proteins, that
in turn are coupled to telomeres through the nuclear envelope (NE), leading to large-scale active telomere-led
motions. But these telomere motions are randomly directed, raising the question of how exactly they facilitate
pairing. In addition to random telomere movement, the meiotic nucleus can undergo an extensive re-
organization, including clustering of telomeres to form a bouquet, coupling of centromeres between non-
homologous chromosomes, and pre-meiotic homolog alignment, depending on the organism. Here we will
investigate the cellular mechanism of meiotic pairing by testing a set of hypotheses regarding the role of
telomere-led active motion and nuclear re-organization in increasing the fidelity of pairing, reducing the extent
of homology searching, and avoiding or reducing interlocks between chromosomes. Our work uses live-cell
imaging combined with genetic manipulation in budding yeast as a model system.

Public health relevance
Project Relevance/Narrative Chromosome missegregation during meiosis is directly tied to human infertility and is also the leading known genetic cause for mental retardation and developmental disabilities. This work investigates the mechanisms in place to ensure faithful chromosome pairing during meiosis since in order for chromosomes to segregate, they must first find their homologous partner. Such research may lead to new ideas for treatment of infertility or to development of diagnostic tests to detect potential problems of chromosome segregation early on.